Evolutionary multispecies transcriptomics to reveal genes that govern fungal spore germination and pathogenesis

Project Summary
Fungal pathogens of humans are prevalent in the environment, and commonly come into contact with hosts
via dispersal of vegetative spores. Although spore germination and subsequent development are recognized as
critical to the initiation of fungal-host interactions, little is known about the fungal genes that govern these events.
Our goal is to leverage comparative genomics, evolutionary biology and fungal pathogenesis to define genes
that are essential for spore germination, subsequent growth, and host colonization in an evolutionarily diverse
group of fungi. We have chosen fungi with a range of abilities to cause disease upon interaction of spores with
mammalian hosts, including primary, opportunistic, and nonpathogenic species. We will take advantage of a
highly effective and innovative pipeline that reveals genes whose evolving roles have led to phenotypic
differences among these species. PIs Trail and Townsend have defined a paradigm that brings together
comparative genomics, developmental biology, and transcriptomics into a single, unified phylogenetic framework
that will identify key genes that govern spore germination and outgrowth in these fungi. The linchpin of our
approach is use of the evolutionary relationship between the fungi to infer genes whose expression has been
altered during evolution from their ancestral state to each present-day lineage, thus allowing specific traits (such
as pathogenesis) to evolve. In our recently published work and preliminary data, this approach was immensely
powerful for identifying genes whose evolving role led to developmental and phenotypic differences among
species during (1) fungal sexual development and (2) spore germination and early infection during fungal
pathogenesis of plants.
We will use a common medium to germinate spores from the following fungi: the primary pathogens
Histoplasma capsulatum and Coccidioides posadasii, the opportunistic pathogens Aspergillus fumigatus,
Fusarium oxysporum, and Chaetomium elatum, the infrequent opportunistic pathogen Aspergillus nidulans, and
the non-pathogenic Neurospora crassa. We will subject these fungi to transcriptomics over a time-course of
germination and subsequent development under temperature conditions relevant to germination in the
environment vs. in a mammalian host. We will reconstruct evolutionary changes of gene expression across these
multiple species to identify genes that have undergone recent shifts in gene expression, in particular shifts that
occurred along the shared ancestral branches where key traits (such as the ability to colonize mammals) have
evolved. These experiments will yield a high-confidence set of candidate genes whose function is expected to
be critical for spore germination and development in each organism. We will use gene knock-out technology to
interrogate the function of these candidate genes in spore germination and development. These studies will
identify potential targets for diagnostic, prophylactic, and vaccine interventions for ubiquitous fungal infections of
humans.

Public health relevance
Project Narrative Fungal pathogens cause devastating diseases in humans: for ubiquitous environmentally acquired pathogens such as Aspergillus fumigatus, Coccidioides posadasii, and Histoplasma capsulatum, the key initial interaction occurs when fungal spores germinate and grow in the environment of the host. The proposed work will characterize fungal factors that are required for spore germination and subsequent disease initiation, significantly advancing our understanding of the basic biology of fungal pathogenesis. Additionally, this work will contribute to the discovery and implementation of novel diagnostic tools, prophylactic interventions, and vaccines for fungal disease.